The AnVIL Data Ecosystem

Project Summary The AnVIL environment uses leading cloud-scale cyberinfrastructure as the foundation supporting the most widely-used analysis environments and frameworks vetted by NHGRI researchers. The overall goals of this ODSS supplement proposal are to enhance the user experience and increase interoperability, data access and sharing, and data visibility. To accomplish these objectives, we propose seven aims, each tackling components of data access, shareability, and visibility. In combination, all aims will significantly improve the user experience in AnVIL. Aim 1. FHIR work: In order to address challenges in searching and exchanging data across biomedical research systems, we are expanding work with FHIR to include creating an AnVIL FHIR app and stand up single user tenants for FHIR for users to easily load their EMR data into AnVIL. Aim 2. Terra as a GA4GH Passport Broker: To modernize and expand data access permissions, the AnVIL will harness the power and standardization of RAS. Further, enabling Terra as a GA4GH passport broker, we combine access control through whitelists, dbGaP authorizations, and other passport brokers to greatly improve data access control. Aim 3. Terra supporting DRS 1.x as a server: In an effort to improve AnVIL’s capacity to onboard and use data within other partners, we will continue expansion of DRS support in Terra. This work aligns AnVIL in the larger ecosystem of trusted partners. Aim 4. NCPI Portal and Dataset indexing: To expand data visibility, the NCPI Dataset Catalog will build an automated mechanism to interface directly with the platform APIs to allow querying and to retrieve the study information and associated metadata. Direct access to the platform's FHIR server will reduce the manual effort and hence improve the quality and timeliness of the data. Aim 5. Standardization of apps across Platforms: To ease deployment of complex applications within AnVIL thereby moving toward a comprehensive platform, AnVIL will extend the app standardization created in BioData Catalyst with the Kubernetes support to dramatically increase flexibility and extensibility of the AnVIL platform. Aim 6. FHIR Codeathon: In an effort to engage NCPI platforms and scientific community members in developing tools that leverage FHIR-represented research data and APIs, we will host a series of Virtuaal FHIR Code-a-thons. Aim 7. NIH DUOS Pilot Expansion: To address scalability challenges, the AnVIL will extend the DUOS pilot program to five new groups allowing us to pull together qualitative information on DUOS pilot expansion that will promote the use and adoption of DUOS by Data Access Committees.

Public health relevance
Project Narrative Accessible, well-organized, secure, and efficiently operated data resources are critical to modern scientific inquiry. The goals of this proposal advance the AnVIL project and platform and ODSS mission by enhancing the user experience and increase interoperability, data access and sharing, and data visibility.